Lymphatic regulation of lymph node function in lupus

Patients with systemic lupus erythematosus (SLE) are photosensitive, demonstrating an increased skin
sensitivity to ultraviolet radiation (UVR) whereby even ambient exposure to sunlight can result in the
development of inflammatory skin lesions. Beyond the skin, however, UVR exposure can also trigger systemic
disease flares, with increased circulating autoantibodies and further injury of end organs. The mechanisms by
which UVR exposure at the skin can lead to flares of systemic autoimmunity are not well understood. Our
long-term goal is to delineate the mechanisms that connect photosensitivity with systemic disease flares. Skin
communicates with the immune system via lymphatic vessels which serve both to remove interstitial fluid from
skin and bring antigens and mediators to regulate draining lymph node immune function. Compromised
lymphatic flow results in increased and prolonged skin inflammation and alters the signals that reach the lymph
nodes, resulting in autoantibody generation over the long term. The importance of lymphatic flow in both skin
and lymph node regulation led us to examine lymphatic flow function in SLE. We show evidence of
compromised lymphatic flow in human SLE and multiple mouse models and that improving lymphatic flow in
SLE models reduces skin photosensitivity and draining lymph node plasmablast responses. Our goal with this
proposal is to understand the mechanisms by which lymphatic flow regulates draining lymph node immune
responses in lupus-like disease. We show preliminary data that improving lymphatic flow increases lymph
node fibroblastic reticular cell (FRC) expression of CCL2, driving the FRC-monocyte-plasmablast axis that
limits plasmablast survival. Improving lymphatic flow also downregulated skin interferon-I (IFN-I)-stimulated
gene expression and upregulated FRC CCL2 was dependent on the NOX2 subunit of NADPH oxidase.
Improving lymphatic flow additionally upregulated FRC expression of IMP2, an RNA binding protein that
detects N6-methyladenosine RNA modifications and stabilizes CCL2 mRNA, and regulatory T cell
accumulation in lymph nodes. These data suggest the following hypothesis: Improving lymphatic flow
reduces IFN-I signaling, upregulating FRC NOX2-mediated reactive oxygen species generation that drives an
IMP2-mediated program of FRC alterations. The resulting FRC CCL2 upregulation modulates monocyte and
regulatory T cell function in lymph nodes, limiting B cell responses. Our aims are to 1) delineate the
relationship between IFN-I and Nox2 in regulating FRC CCL2, 2) Understand the extent of contributions of
IMP2 to lymphatic-driven FRC phenotypic alterations, and 3) understand the mechanisms by which lymphatic-
driven FRC regulation reduces B cell responses. The proposal will help us understand how lymphatic function
contributes to lupus-like disease and delineate mechanisms by which FRCs are regulated and shape lymph
node function, paving the way to better understanding the relationship between photosensitivity and
autoimmunity.

Public health relevance
Narrative Patients with systemic lupus erythematosus and other autoimmune diseases can develop systemic disease flares upon even ambient sunlight, but the mechanisms are poorly understood. Here, we will examine the how the flow of information from skin to immune tissues via lymphatic vessels modulates skin and immune function.